Genomic and functional approaches to characterize Chr1q gains in cancer

Aneuploidy is a ubiquitous but poorly-understood feature of tumor genomes. For instance, approximately 25%
of human cancers harbor extra copies of the “q” arm of chromosome 1, making this amplification more common
across cancer types than mutations in KRAS, PIK3CA, RB1, and many other widely-studied cancer driver genes.
Despite the prevalence of 1q aneuploidy in cancer, we have little insight into its role in tumorigenesis. While
evolutionary studies have defined consistent patterns in which single nucleotide substitutions occur in oncogenes
and tumor suppressors during cancer development, the relative timing of most copy number alterations remains
unknown. Additionally, while multiple approaches have been developed to experimentally manipulate single
genes in cancer, our ability to alter and study chromosome-scale dosage changes is extremely limited. Thus, we
lack genetic strategies that would allow us to develop a mechanistic understanding of how aneuploidies like
Chr1q gains influence cancer biology.
We hypothesize that certain commonly observed aneuploidies like Chr1q-amplifications may function as cancer
“addictions”, in the same way that some cancers can be addicted to oncogenes like KRAS and PIK3CA.
Eliminating these aneuploidy “addictions” could therefore block cancer growth and suppress various malignant
phenotypes. To investigate this hypothesis, and to uncover the role of 1q-gains in cancer biology more broadly,
we have developed novel computational and functional approaches to study cancer aneuploidy. In preliminary
work, we discovered that Chr1q gains are commonly the first arm-scale copy number change that occurs during
tumor development, and we found that genetically eliminating Chr1q aneuploidy prevents malignant growth in
human cancers. To build on these findings, in Aim 1, we will optimize and apply a strategy to reconstruct the
evolutionary timing of somatic copy number alterations from multi-sample sequencing studies of human tumors.
In Aim 2, we will apply a novel chromosome-engineering approach to eliminate Chr1q aneuploidy from human
cancers, and then we will characterize how aneuploidy-loss affects various malignant phenotypes. In Aim 3, we
will identify the dosage-sensitive driver genes encoded on Chr1q that contribute to this “aneuploidy addiction”
phenotype. In total, these aims will shed light on the functional consequences of an enigmatic genomic alteration
found in many cancers. As 1q gains commonly arise during malignant growth but are extremely rare in normal
tissue, a greater understanding of this aneuploidy could point toward treatment strategies that are effective
against a wide range of tumors but that have little effect on normal diploid tissue.

Public health relevance
Project Narrative Approximately 25% of human tumors harbor a gain of the “q” arm of chromosome 1, but the functional consequences of this large-scale dosage change are unknown. We will develop and employ novel computational and genetic strategies to characterize the functional consequences of this alteration. These studies will shed light on the physiological effects of a ubiquitous but poorly-understood feature of tumor genomes.